Catalytic and Regulatory Mechanisms of Heme-based Dioxygenases

SUMMARY
Human indoleamine 2,3-dioxygenases (IDO1 and IDO2) and tryptophan dioxygenase (TDO) are crucial hemeproteins
responsible for catalyzing the first and rate-limiting step of the kynurenine pathway that serves as the primary metabolic
route for breaking down L-tryptophan (Trp), the least abundant essential amino acid. By depleting Trp and facilitating
the generation of bioactive kynurenine metabolites, these enzymes play a diverse role in immunomodulation.
Accordingly, they have been implicated in a variety of pathological conditions, including cancer, and have been
recognized as pivotal targets for therapeutic intervention. Extensive research in drug discovery targeting these enzymes
has been initiated. The advances, however, have been significantly impeded by the poor understanding of the molecular
properties of these enzymes. Our research program has made critical contributions in shaping our current understanding
of these important dioxygenases at a molecular level, through unraveling the intricate details of the enzyme structures,
substrate-selectivity, ligand-binding dynamics, dioxygenase activity and inhibitory mechanisms. We will continue our
research endeavors in advancing the field by synergizing our efforts and expanding them to (i) define cellular metabolite-
protein interactions and the associated regulatory mechanisms, (ii) unravel the catalytic diversity and the related
enzymatic mechanisms, and (iii) delineate critical inhibitor-protein interactions for effective drug design. To achieve our
goals, we will employ a multifaceted approach with a combination of spectroscopies, crystallography, calorimetry, high
throughput mass spectrometry, protein engineering and computational simulations. The outcome of our research will (i)
offer novel insights into the mechanisms by which the dioxygenases are regulated by cellular metabolites in the cellular
milieu, (ii) fill in crucial knowledge gaps in structure-function relationships of the dioxygenases and heme oxygen
chemistry, and (iii) expand our toolkit for rational design of enzyme-selective inhibitors.

Public health relevance
Narrative Human tryptophan dioxygenase (TDO) and indoleamine 2,3-dioxygenases (IDO1 and IDO2) are key components of immune evasion associated with numerous diseases. This research program aims to delineate the structure-function relationships of the three dioxygenases. It is relevant to public health as the outcome of this program will advance our understanding of the mechanisms by which dioxygenases contribute to human health and diseases.